Supplement to AWD32581 - Fritz fellowship F32CA220935

PROJECT SUMMARY No changes during requested extension period.

Public health relevance
PROJECT NARRATIVE No changes during requested extension period.